Metabolism, Transcription and Disease

? DESCRIPTION (provided by applicant): Support is requested for a Keystone Symposia meeting entitled Metabolism, Transcription and Disease, organized by Peter Verrijzer, Katherine A. Jones and Paolo Sassone-Corsi. The meeting will be held in Snowbird, Utah from January 10-15, 2016. To maintain homeostasis, cells need to coordinate gene expression and metabolic state. There is increasing evidence that misregulation of metabolic flux and gene transcription plays a major role in human diseases, including obesity, diabetes and cancer. The aim of this meeting is to explore how metabolic state influences gene expression programs and, conversely, how intermediary metabolism is controlled by the transcription machinery and chromatin-modulating enzymes. Particular emphasis will be on the connection between gene transcription and metabolism in homeostatic and diseased state. Emerging evidence emphasizes that chromatin-modifying enzymes depend on substrates, or co-factors, that are key components of intermediary metabolism. The cellular concentration of these metabolites fluctuates in response to, for example, nutrient availability, circadian cycles or oncogenic transformation. Thus, chromatin might be considered a sensor of metabolic state. Moreover, some metabolic enzymes play surprisingly direct roles in transcription control. Conversely, transcriptional control of metabolic enzyme expression, for example by nuclear receptors or the oncogene Myc, plays a major role in maintaining homeostasis, circadian rhythm or driving cell growth and proliferation. The aim of this Keystone Symposia meeting is to bring together scientists working on basic aspects of transcription control, epigenetics, metabolic disease and cancer. The meeting should serve as a discussion platform to explore the rapidly growing interface between transcription regulation, metabolic reprogramming and human disease. Opportunities for interdisciplinary interactions will be significantly enhanced by the concurrent meeting on Nuclear Receptors: Full Throttle, which will share a keynote address and two plenary sessions with this meeting.

Public health relevance
PUBLIC HEALTH RELEVANCE: One of the emerging frontiers in molecular biology is the connection between metabolism and gene control. However, there is still limited cross-fertilization between research on metabolism and that on gene expression and, thus far, no meeting has been organized that is dedicated to this interface. The Keystone Symposia meeting on Metabolism, Transcription and Disease provides a unique blend of leading researchers in the transcription, epigenetics and metabolic signaling fields, connected through major human diseases such as cancer, diabetes and obesity. By bringing together scientist working on diverse aspects of these processes, we hope to uncover novel concepts, unappreciated connections and parallels.